Breakthrough High-Accuracy, High-Throughput Colorectal Cancer Screening Platform

Project Summary/Abstract
Screening for colorectal cancer (CRC) and precancerous lesions, such as advanced adenoma (AA), represents
a significant healthcare challenge. Current approaches, including colonoscopy and stool-based tests, suffer from
limitations such as invasiveness, inconvenience, cost, and variable sensitivity. Addressing this need, we propose
leveraging Intus Biosciences' Titan-1 platform lab developed test, designed for non-invasive high-throughput
fecal microbiome profiling with at-home sample collection, as a novel CRC screening tool.
Training the Titan-1 machine learning algorithm with a limited CRC/AA sample dataset of 57 CRC fecal samples
yielded CRC screening results equivalent to existing fecal CRC screening tests. We show that results improve
as more data is used for training the machine learning. This approach is unique in that it offers the opportunity
to enhance sensitivity and specificity for CRC detection by augmenting the Titan-1 training dataset with a
surprisingly small number of additional CRC samples. By doubling the number of control samples to a few
hundred, and simultaneously adding about 100 additional CRC samples, we anticipate exceeding current
sensitivity and specificity benchmarks of existing market leading products.
Furthermore, the platform can detect precancerous AA lesions, and we propose to improve AA detection by
incorporating 100 AA samples into the Titan-1 training dataset, aiming for sensitivity and specificity in excess of
75%, with a stretch goal of 96%. Initial results with 35 AA samples showed modest sensitivity similar to results
with 35 CRC samples, but we hypothesize that additional AA samples will yield significant sensitivity
improvements, similar to CRC detection results.
If Phase 1 is successful Phase 2 will focus on FDA submission for CRC and AA screening device approval,
demonstrating superior sensitivity and specificity compared to existing devices, along with comprehensive safety
and performance data. The final product will decrease invasiveness, inconvenience, cost and will significantly
increase convenience and accessibility compared to colonoscopy and will provide a more sensitive non-invasive
test for precancerous lesions. Preliminary discussions with FDA advisors suggest that Phase 1 results will be
instrumental in initiating discussions with the FDA regarding Titan-1 device approval.

Public health relevance
Project Narrative This proposal provides a roadmap to show that Titan-1, a commercially available lab developed test for fecal microbiome profiling, can overcome sensitivity and specificity challenges of current fecal colorectal cancer (CRC) and advanced adenoma (AA) products for non-invasive, high-throughput CRC screening. Enhancing sensitivity and specificity by incorporating Titan-1 data from CRC and AA samples into the machine learning algorithm is expected to potentially surpass existing benchmarks for CRC screening products, paving the way for Phase 2 FDA submission and approval as a superior CRC and AA screening tool.